Multidisciplinary Research Training in Gastroenterology and Hepatology

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The successful sequencing of the human genome and the evolution of human health services research in the post-genomic era have offered unprecedented opportunities to transform patient care in digestive diseases. Over the past decade, Weill Cornell Medicine (WCM) has made major investments in biomedical research, as well as research training and infrastructure. This application from WCM that requests support for the research training of six clinical and non-clinical postdoctoral fellows in a renewal application for multidisciplinary research training program (MRTP) in Gastroenterology and Hepatology, with WCM providing funding for an additional training slot. The objective is to recruit outstanding candidates with solid foundations in basic science and train them to apply their knowledge and skills towards addressing important clinically unmet needs in the prevention, diagnosis, and treatment of patients with digestive diseases. MRTP trainees will receive program support for two years during which they will follow a structured and rigorous postdoctoral training program. The MRTP will be a joint effort of 31 eminent preceptors from WCM, Memorial Sloan Kettering Cancer Center (MSKCC) and the Rockefeller University (RU), which constitute a dense network of collaborative researchers, who are international leaders in fields directly relevant to gastroenterology and hepatology. These preceptors have been organized into 3 themed, but interconnected units of research training: gastrointestinal epithelial cell biology, liver diseases, and mucosal immunology and inflammation. These training units will enable the development of content-specific educational programming, as well as increase the efficiency administration within the training program. Oversight will be provided by a Research Training Executive Committee consisting of the Program Director, 3 Associate Program Directors, and 3 additional members who will provide specific guidance on clinical/epidemiologic research within the training program. Three senior preceptors will serve as leaders of the individual training units. We have also assembled an outstanding roster of internal and external advisory board members with a mandate to evaluate the program and provide specific recommendations to improve both its quality and efficiency. The MRTP’s highly personalized training program will include 1) individual development plans; 2) rigorous research training; 3) hands-on experience in cutting-edge methodologies; and 4) an integrated curriculum. Trainees will further benefit from the extensive institutional resources of WCM, MSKCC and RU. Based upon the levels of interest in our fellowship programs, we anticipate a substantial pool of highly qualified clinical and non-clinical candidates for the proposed MRTP. Through its rigorous, structured and highly personalized curriculum, this training program seeks to train future leaders in digestive disease research who are prepared to translate their findings towards improving patient care.

Public health relevance
PROJECT NARRATIVE This Multidisciplinary Research Training Program in Gastroenterology and Hepatology addresses the critical need for more physician-scientists and scientists focused on gastrointestinal and liver diseases. This Program will provide postdoctoral fellows with rigorous, personalized and state-of-the-art research training. The overarching goal is to equip outstanding young researchers with the knowledge and skills required to accelerate the translation of basic science discoveries into new approaches to the diagnosis and management of digestive disorders.